Hematopoiesis

ABSTRACT Support is requested for a Keystone Symposia meeting entitled Hematopoiesis, organized by Drs. Catriona H.M. Jamieson, Andreas Trumpp and Paul S. Frenette. The meeting will be held in Banff, Alberta, Canada from January 31 – February 4, 2017. Since the discovery that hematopoiesis could be established by a single cell over five decades ago, advances in model systems, sequencing, reprogramming and genome editing technologies have enabled precise molecular characterization of regulators of hematopoiesis. These discoveries have informed and accelerated implementation of clinical trials for a broad of array of benign and malignant hematologic disorders, including bone marrow failure syndromes and leukemia, as well as guided the development of molecular prognostication strategies. This meeting will bring together basic, translational and clinical researchers to discuss key regulators of hematopoietic stem and progenitor cell ontogeny, cell fate specification and self-renewal during homeostasis, stress and malignant transformation. The relative importance of cell-autonomous genetic, epigenetic, transcriptional and post-transcriptional hematopoietic regulatory mechanisms as well as local niche or systemic factors will be presented by international leaders in the field of hematopoiesis and stem cell biology. The culmination of innovative genome editing, reprogramming, single-cell sequencing and imaging in different model systems to unravel essential regulators of hematopoiesis will be highlighted. We anticipate that this meeting will provide a vital opportunity for forging collaborations between researchers from disparate disciplines and result in novel insights from a plethora of model systems that will enable investigators to address basic, translational and clinical hematopoiesis research challenges.

Public health relevance
PROJECT NARRATIVE The hematopoietic system is unique in that it has served as an important model for understanding mechanisms of development, proliferation, survival and lineage choice in a mammalian regenerating tissue. In addition, a long history of successful clinical experience with bone marrow transplantation and hematologic malignancies has reinforced and enriched the principles learned from experimental systems. The 2017 Keystone Symposia meeting on Hematopoiesis will provide a forum for cross-fertilization among a spectrum of basic to clinical researchers who cover various aspects of hematopoiesis encompassing stem and progenitor cell development, maintenance and differentiation during homeostasis, stress and disease.